RESEARCH IN HUMAN COMMUNICATION AND ITS DISORDERS

PROJECT SUMMARY/ABSTRACT
This application requests support for three postdoctoral positions in a multidisciplinary research training
program in the area of human communication and its disorders at Boys Town National Research Hospital
(BTNRH). The training program at BTNRH, currently in its 39th year, has provided postdoctoral training to a
substantial number of highly qualified scientists who are presently working in the field of communication
disorders. The purpose of the program is to fulfill two basic training needs: 1) advanced research training for
applicants who are recent graduates of speech and hearing, communication sciences or language-related
doctoral programs, and 2) training for applicants with a received doctorate in a related field of science,
technology, engineering or mathematics who would benefit from additional research experience in a
collaborative, research-intensive environment. The training program consists primarily of direct participation by
trainees in behavioral and clinical translational research under the sponsorship of one or more experienced,
independent scientists serving on the program faculty. Research at BTNRH is conducted in a wide range of
disciplines and laboratories from clinical audiology to language development, with the focus on questions
concerning the mechanisms underlying human communication and its disorders. The unique advantages of the
BTNRH research environment for the training program include: 1) a faculty consisting of 16 behavioral, clinical
and translational clinical scientists who serve as mentors; 2) a critical mass of research trainees, funded by a
variety of mechanisms, including T32, F32, COBRE and R01 grants; 3) a clinical staff with access to a large
and varied pediatric and adult patient population; 4) modern, well-equipped laboratories and diagnostic clinics;
5) a stimulating mix of areas of research across individual research laboratories; 6) access to support from
software and hardware developers within BTNRH’s Technology Core; 7) access to support in human subject
recruitment and standard clinical testing from BTNRHs’ Human Subjects Core and 8) conditions that foster
collaborative, multi-disciplinary research.
Trainees are selected from PhD's, DSc's, and MD’s in areas relevant to ongoing research programs at
BTNRH on the basis of their research capabilities and the likelihood of their interacting productively with
training faculty. Particular attention is paid to identifying and inviting applications to the program from under-
represented minority candidates and candidates with a disability. Every effort is made to enhance diversity in
the postdoctoral training program and eventually in the group of scientists performing research related to the
mission of the NIDCD.

Public health relevance
PROJECT NARRATIVE There is a critical need for interdisciplinary research in the area of human communication and its disorders. The Boys Town National Research Hospital postdoctoral training program is designed to provide trainees with the expertise required to develop successful independent research programs through training in a large center comprising a highly collaborative and unique mix of behavioral and clinical translational research programs.